Cancer Community Outreach Core

PROJECT SUMMARY: CANCER OUTREACH CORE
The Cancer Outreach Core (COC) will apply a community-engaged research (CEnR) framework to facilitate and
nurture integration and partnership between the institutions in our Meharry Medical College/Vanderbilt-Ingram
Cancer Center/Tennessee State University Cancer Partnership (MVTCP). The COC will engage with our
community partners to incorporate meaningful community engagement into research and outreach to ensure
that MVTCP activities are reflecting the needs and concerns of those populations that are most affected by
cancer health disparities in the 14-county Nashville Metropolitan Statistical Area. The overarching goal of the
COC is to facilitate the reduction of cancer health disparities by leveraging the strengths of community partners to
support and enhance cancer research and outreach efforts which will be addressed by the following Specific Aims:
1) enhance community collaborations to accelerate research and implementation of programs and policy
designed to reduce cancer burden and disparities; 2) facilitate strategic research and diverse/inclusive clinical
trial participation relevant to community needs; and 3) develop innovative outreach and education strategies to
support capacity building of MVTCP stakeholders. These aims will be achieved through the collaboration of the
COC with other MVTCP cores, through a robust Community Advisory Board (CAB), and through regularly
consulting with MVTCP research projects. Given the significant regional mortality disparity among Black (compared
to white) men with prostate cancer, a CAB member representing the Prostate Cancer Coalition of Tennessee
collaborated on the pilot work that led to the submission of a full project in this renewal on prostate cancer. The higher
regional rates of ovarian cancer led to the formation of an ovarian cancer support group established through a CAB
member, enabling ongoing support of a pilot project focused on ovarian cancer. During the last grant period, COC
helped to foster incorporation of dissemination and implementation science into the CEnR which contributed to the
full project in this renewal focused on breast cancer risk assessment. The COC will facilitate bi-directional
communications, bringing community input to the projects and disseminating results to the community. Furthermore,
MVTCP investigators leading research projects will provide presentations to the CAB and receive feedback on
presenting to lay audiences. With coordination through the Administrative Core, the COC will collaborate with
the Translational Pathology and Population Research and Clinical Trials in Cancer Equity Shared Resource
Cores to develop an educational module about biospecimen donation. With the Research Education Core
students will be engaged in community outreach utilizing new technologies aiming to reduce cancer disparities.
The Biostatistics and Bioinformatics Shared Resource Core will provide input on quantitative analyses required
for CEnR projects. The Planning and Evaluation Core will participate in the